Understanding and preventing heavy drinking and related HIV-risk behavior among active-duty men who have sex with men

PROJECT SUMMARY / ABSTRACT
HIV infection rates in the U.S. military have doubled since 2003, yet no interventions targeting HIV
transmission in this population have been tested in over 15 years. Eighty percent of new infections occur
among active-duty men who have sex with men (AD-MSM) – a population that is critically understudied due to
a long history of policies that prevented researchers from asking service members about sexual identity or
same-sex behavior. Permitted since 2012, research on behavioral health among AD-MSM remains scarce.
Initial evidence suggests that HIV prevention for AD-MSM should target alcohol-related sexual risk behavior
(AR-SRB). The causal link between alcohol use and risky sex is well established. Heavy drinking is prevalent
among service members, highest among AD-MSM, and driven by highly pro-drinking military social norms.
Alcohol misuse and risky sex are also both link to traumatic stress, particularly sexual assault, and AD-MSM
have over 5 times greater odds of military sexual trauma (MST) relative to their straight male peers. Pre-
exposure prophylaxis (PrEP), a common target of current civilian HIV prevention efforts, is less viable for AD-
MSM due to significant social and structural barriers unique to the military – persistent stigma, absence of
medical confidentiality, unavailability of PrEP at many installations, and prohibitions against its use by service
members on deployment, shipboard, or in certain occupational specialties. Internet-based personalized
feedback interventions (iPFI) are an ideal modality to address AR-SRB among AD-MSM. Delivered privately,
iPFI has shown efficacy for reducing heavy drinking and related problems. The present 2-phase study seeks to
develop a trauma-informed iPFI targeting both heavy drinking and sexual risk behavior among AD-MSM.
Phase 1a: A survey of 160 AD-MSM will establish behavioral norms and provide data to test a novel behavioral
framework describing traumatic stress and military culture as pathways to AR-SRB. Phase 1b: Qualitative
interviews of 15 AD-MSM will contextualize AR-SRB and gather feedback on draft iPFI components. Phase 1c:
We will finalize a novel iPFI based on findings and extant iPFI models. Phase 2: A randomized controlled trial
(N=50) will provide data on intervention feasibility, acceptability, and preliminary efficacy. Pilot data will be
used for an R01 application to NIAAA seeking to test the further-refined iPFI in a fully powered RCT. The
training plan for this application will focus on growing expertise in intervention development, AR-SRB,
behavioral responses to traumatic stress, AD-MSM health, and methodologies for research on stigmatized
behaviors and hard-to-reach populations. A highly productive team of mentors is committed to Dr. Walton’s
success and will each contribute unique expertise to his research and training plans. Support from this award
is crucial to Dr. Walton’s development as an independent scientist, in the vanguard of scholarship on AD-MSM,
who can conduct meaningful research on the prevention of both alcohol misuse and HIV.

Public health relevance
PROJECT NARRATIVE Rate of HIV infection among U.S. military personnel has doubled in the past two decades, yet no HIV prevention interventions targeting this population have been tested in over a decade, and research on active- duty men who have sex with men (AD-MSM), who account for over 80% of new infections, was forbidden by federal policy for the first three decades of the HIV/AIDS crisis. HIV prevention interventions targeting AD-MSM should focus on alcohol-related sexual risk behavior (AR-SRB) given the high prevalence of heavy drinking within the population, the significant link between heavy drinking and sexual risk behavior, and barriers within the military health system that substantially limit pre-exposure prophylaxis as a viable prevention strategy for AD-MSM. The present study seeks to significantly expand our understanding of alcohol use and sexual risk behaviors within the notably understudied population of AD-MSM and to develop, then pilot test, an internet- based personalized feedback intervention motivating self-directed change in both heavy drinking and sexual HIV-risk behaviors among AD-MSM.